Quantifying organism-environment interactions in a new model system for neuroscience

PROJECT SUMMARY
Studies of model organisms have revealed many insights into how animals sense their environment and how
this input is processed by their brains to produce behavioral output. However, our current understanding of
how the brain controls behavior is derived from a handful of species that share certain features, e.g., their
brains are highly regionalized and stereotyped. Yet, not all animal brains are structured in this manner, and to
identify general principles for the control of animal behavior, a broader diversity of brains needs to be
investigated. We will study the acoel worm, Hofstenia miamia, which is a new research organism with key
features that position it to address major questions in behavioral neuroscience. First, Hofstenia, a voracious
mangrove predator, is a marine invertebrate that performs complex behaviors in the lab, and our recent work
has shown that it is amenable to rigorous, quantitative studies of its behaviors and of behavior-induced
physical changes in its aquatic environment. Second, as an acoel, Hofstenia diverged from models such as
flies and mice 550 million years ago and possesses a brain that does not show evidence of regionalization,
providing an opportunity to study distributed computation. Third, the Hofstenia brain can regenerate from any
starting condition, enabling the study of how robustness is encoded in the brain. Fourth, Hofstenia is highly
tractable in the lab, offering many genomic resources and tools for functional genetics, which will make it
possible to collect neural activity data. Given these features, the overall objective in this proposal is to leverage
Hofstenia to study its behavior and environment at the whole-organism level. Specifically, we aim to: 1)
Develop methods for rigorous measurement and quantification of worm behavior and its environment, using
pose estimation to infer worm action sequences, water flow measurement to quantify physical changes around
worms, and tracking of prey to quantify the worm’s biological environment. 2) Perturb both organism and
environment to uncover mechanisms of behavioral control. We will amputate animals to determine how
regenerating brain features correlate with elements of behavior, and deliver artificial mechanical flow stimuli to
understand how animals read their physical environment. 3) We will assemble a team of researchers with
expertise in behavioral neuroscience, pose estimation, connectomics, neural activity dynamics, fluid
mechanics, computational modeling of behavior, and in the organism and its regenerative abilities to plan work
that will enable the integration of neural activity data with behavioral and environmental data to reveal how
distributed computations in the brain enable the animal to produce action sequences that successfully navigate
the environment and capture prey. This proposal is innovative in its use of a new research organism, in its
pursuit of behavior-environment quantification in the whole-organism context, and in its potential to reveal
general principles of behavioral control, particularly via distributed computation.

Public health relevance
PROJECT NARRATIVE This project aims to develop a new animal model for neuroscience that allows synchronous measurement of behavior and of the environment at the level of the whole organism. This species possesses the remarkable capacity to maintain robust brain function despite substantial damage and is also amenable to measurement of neural activity. In the long term, this work will reveal fundamental principles of how the brain controls behavior and its robustness.